On the plasticity of Beta-cell antigen recognition by diabetogenic CD8 T cells

Project summary
CD8 T cells play an essential role in T1D pathogenesis. They comprise the most abundant immune cell
population in patient islet infiltrates. In the non-obese diabetic (NOD) model of T1D, they are required for
diabetes development. The infiltration and retention of autoreactive T cells in islets is strictly dependent on
specific recognition of beta-cell antigens. Such self-recognition also determines diabetogenic CD8 T cell’s
cytotoxicity and ultimate killing of beta-cells. However, little is known about how CD8+ T cells recognize beta-
cell antigens. Over the past decade, we have used novel 2D assays to characterize T cell antigen recognition
in general, revealing 2D affinity and mechanical force as two defining kinetics parameters in determining T cell
responses. In the current proposal, we will apply these 2D methods to beta-cell antigen recognition by
autoimmune CD8 T cells and elucidate the underlying molecular mechanisms by single cell RNA sequencing.
Our preliminary data show that diabetogenic CD8 T cells can greatly change affinity and/or force of self-antigen
recognition depending on T cell maturation, activation, and disease status. We propose two specific aims to
test a central hypothesis that diabetogenic CD8 T cells bind to beta-cell self-antigens weakly to evade
tolerance mechanisms but can upregulate bond strength to drive disease. In Specific Aim 1, we will use our 2D
methods to characterize affinity and force of beta-cell antigen recognition by CD8 T cells throughout the course
of diabetes. In Specific Aim 2, we will use single cell transcriptome analysis to elucidate molecular mechanisms
that abnormally regulate beta-cell self-antigen recognition. The project will generate critical yet currently
missing information on beta-cell self-antigen recognition and inform novel intervention strategies that are
capable of specifically targeting diabetogenic CD8 T cells.

Public health relevance
PROJECT NARRATIVE The current project investigates pathogenesis of Type I Diabetes (T1D) from the point view of autoimmune T cell antigen recognition – a critical event that initiates and perpetuates T1D. We will use novel single cell/single molecule technologies to characterize beta-cell self-antigen recognition by diabetogenic CD8+ T cells and perform transcriptome analysis to elucidate the underlying molecular mechanisms. A mechanistic understanding of anomalies of self-recognition (compared to normal foreign-recognition) will provide new insights to specifically target diabetogenic T cells, which may ultimately offer a cure for T1D that is urgently needed.